Functional characterization of the Alzheimer's disease Epigenome

Project Summary/Abstract Alzheimer’s disease (AD) manifests as a devastating age-related progressive neurodegeneration. This neurodegeneration and the concomitant loss of cognitive function plagues more than 44 million individuals worldwide. Our understanding of the molecular pathogenesis of AD remains incomplete and no therapies exist to prevent, stop, or cure the associated neurodegeneration. This marks one of the greatest unmet clinical needs of our time. Through decades of research, genome-wide association studies have identified heritable coding and non-coding mutations that lead to an increased risk of developing AD. Many of these mutations, however, remain largely under-characterized and their contribution to AD pathogenesis remains unclear. Moreover, it has become increasingly clear that an individual’s lifetime risk of developing AD is not merely governed by genetics. In addition, the epigenome, the complement of all of the chemical and physical modifications imposed on DNA that do not change the underlying sequence, is also thought to play a crucial role. This project aims to define the epigenetic (Aim 1) and genetic (Aim 2) components of AD through profiling of the open chromatin landscapes and three-dimensional chromatin interactions in brain regions and primary cell types of patients with and without AD. These characterizations will identify key AD-related regulatory elements that will be functionally validated with CRISPR interference tiling assays (Aim 3). Taken together, this project will provide an unprecedented picture of the AD epigenome, identifying novel aspects of AD pathogenesis and nominating putative avenues for therapeutic intervention. This work will be performed within the Gladstone Institute of Neurological Disease which is an ideal environment to perform such disease-relevant research, providing all of the facilities needed for the proposed research and a collaborative and enriching culture for an early stage investigator. Cumulatively, this work will launch my independent research program at the intersection of epigenomics and neurological disease.

Public health relevance
Project Narrative Alzheimer’s disease is a devastating neurodegenerative disease, the third most common cause of mortality in the United States, and a looming public health crisis. To date, no approved therapies exist for the prevention or cure of Alzheimer’s disease, highlighting a crucial unmet clinical need. Through the brain regional epigenomic characterization of Alzheimer’s disease and healthy aging, I aim to identify novel aspects of disease pathogenesis and nominate candidate avenues for therapeutic intervention.